MATRIX ASSISTED LASER DESORPTION IONIZATION MASS SPECTROMETRY

Matrix-assisted laser desorption/ionization mass spectrometry (MALDI-MS) is a major advance in the field of biological mass spectrometry, providing high ion yields for low quantities of biopolymers, even in the presence of buffer and other biochemical components that would preclude analysis by other mass spectral techniques. Much of the research in the field to date has concentrated on peptides, proteins, and oligonucleotides, yet the technique also holds considerable promise for oligosaccharide analyses beyond the limited work that has already been demonstrated. This application seeks to develop methods to increase the applicability of MALDI-MS to challenging problems in glycobiology. The research will be directed towards four goals: (1) maximizing the sensitivity for biopolymers, particularly oligosaccharides and glycoconjugates and their derivatives; (2) increasing the information content of the spectra through sample pretreatments that induce mass shifts; (3) developing experimental methods to enhance fragmentation and obtain systematics to help determine the rules of post-source decay fragmentation; and (4) exploring approaches to the analysis of two-dimensional surfaces, both those that occur in biological or biomimetic systems, and those that result from analytical separations or the generation of synthetic product arrays.